Stimulation of Native Joint-resident Precursors for Cartilage Repair in Osteoarthritis

Osteoarthritis (OA), in particular, post-traumatic osteoarthritis (PTOA) is highly prevalent in U.S. military service
members and veterans due to the impact of joint trauma and overuse injury. Its socioeconomic impact is
substantial, estimated to approach $60 billion per year, and no disease-modifying treatments exist. Current
understanding is that PTOA is caused by maladaptive repair responses including activation of the pro-
inflammatory pathways of innate immunity that in turn result in pain, loss of function and structural decline. This
project addresses the hypothesis that promotion of hyaline cartilage repair will effectively alter the course of
PTOA, relieve joint pain and improve joint function. Native mesenchymal stem cells (MSC) residing in the joint
are important targets for manipulation to differentiate into chondrocytes. These joint-resident MSCs include
cartilage progenitor cells, MSCs in synovial fluid, synovium and adipose tissue. SOX9 (SRY-type high-mobility
group box gene-9) is the master transcription factor for chondrogenesis of MSCs. We have produced a
superpositively charged SOX9 (scSOX9) which can penetrate into MSCs and induce chondrogenesis. We
have demonstrated in an acute cartilage injury model that scSOX9 induced hyaline-like cartilage repair by
promoting chondrogenesis of bone marrow derived MSCs (BM-MSCs). By using medial meniscal transection
(MMT) induced rat PTOA model, we will test the therapeutic effect of scSOX9 by harnessing the chondrogenic
potential of these joint-resident MSCs for regeneration of hyaline cartilage. Pain and joint function will be
assessed clinically in live animals by measuring behavior changes at different time points of the disease
course. The degree of cartilage regeneration or repair and synovitis will be quantified by advanced imaging
system. At the termination of experiments, the biomechanical property of the repaired cartilage will be
measured on intact cartilage with subchondral bone using biomomentum indentation technology. Cartilage
degradation, repair and synovitis will also be determined by standardized methods of histopathology and
immunohistochemistry.

Public health relevance
Post-traumatic osteoarthritis (PTOA) is highly prevalent in military personnel and veterans. There is no effective pharmacological treatment for PTOA. This proposal aims to promote regeneration of cartilage of the joint to halt the progression of PTOA by harnessing joint-resident cartilage precursors and stem cells. Results of this project will be highly translatable into clinical development for a novel therapy for PTOA in humans.